Mertk Mediated T Cell Suppression in the Pancreatic Islets During Type 1 Diabetes

PROJECT SUMMARY
In type 1 diabetes (T1D), autoimmunity is established and self-perpetuating within the islets at diagnosis.
Autoreactive T cells in T1D patients destroy endogenous and grafted beta cells, yet there is a gap in
knowledge about the mechanisms by which T cell pathogenesis is modulated in the islets. Evidence from
mouse models of T1D and human samples suggest that myeloid cells play an essential role in this process.
The myeloid compartment represents the largest immune population in non-diabetic and many T1D human
islets. Islet myeloid cells can contribute to islet destruction or protection, yet a significant gap in knowledge
remains about how the islet myeloid compartment plays such divergent roles in islet autoimmunity during T1D
progression. We have shown that Mertk signaling in islet myeloid cells suppresses autoreactive T cell
responsiveness to antigen and prevents rapid progression of T1D. Mertk mediates apoptotic cell uptake
(efferocytosis), and its signaling is immunoregulatory. However, we do not yet understand the mechanisms by
which Mertk signaling in islet myeloid cells suppresses the ability of autoreactive T cells to respond to locally
presented antigen. Our scRNA-seq analyses of myeloid cells from the islets of non-diabetic and T1D organ
donors support that, similar to our mouse data, efferocytosis is enhanced and antigen processing and
presentation are suppressed during the active period of disease following T1D onset. Thus, our overarching
hypothesis is that in the islets during T1D, stimulatory myeloid cell subsets promote pathogenic T cell functions
through antigenic stimulation and inhibitory islet myeloid cell subsets suppress the pathogenic T cells in a
manner that is dependent upon Mertk mediated efferocytosis within the pancreatic islet. To begin to address
the gaps in knowledge about islet myeloid cell function, we propose the following aims: Aim 1: Elucidate the
mechanisms by which Mertk expressing myeloid cells modulate effector and regulatory T cell responses in the
islets. Aim 2: Characterize the myeloid cell subsets that actively present antigen to effector and regulatory T
cells in mouse islets and how this is altered by Mertk signaling. Aim 3: Determine the human islet myeloid
subsets that perform Mertk-mediated efferocytosis and drive T cell signaling in human islets. The successful
completion of this proposal will result in: (1) an improved understanding of the mechanisms used by Mertk-
expressing islet myeloid cells to suppress the islet T cell response, (2) an enhanced understanding of
pancreatic islet myeloid cell subsets and pathways that drive pathogenic T cell activation versus those that
regulate islet autoimmunity and (3) identification of novel therapeutic targets to potentially skew the autoim-
mune T cell response toward protective immunity in type 1 diabetes.

Public health relevance
PROJECT NARRATIVE In type 1 diabetes, myeloid cells in the islets can contribute to destruction or protection of the islets, yet a significant gap in knowledge remains about how the islet myeloid compartment plays such divergent roles. The processes of efferocytosis and antigen processing and presentation are key regulators of this balance. The aims we propose will elucidate the role of these processes in promoting the protective and destructive effects of islet myeloid cells in type 1 diabetes.